In vivo relevance of the Schlafen-mediated innate immune mechanism in flavivirus infection

ABSTRACT
Flaviviruses are important human pathogens including viruses such as West Nile, dengue, and Zika. No
specific treatments or vaccines are available against these infections, and no biomarkers exist that allow
predicting their outcome, characterized by important clinical variability. Understanding innate antiviral immune
responses against flaviviruses, could lead to the identification of disease susceptibility biomarkers and
therapeutic targets. We recently demonstrated that the type I interferon-stimulated protein Schlafen 11
(SLFN11) is a novel and potent flavivirus restriction factor. In this application we aim to define, at the molecular
level, several aspects of the mechanism of action of SLFN11 and determine the anti-flavivirus activity of other
members of the SLFN family, as well as the in vivo relevance of this defense system. Therefore, this
investigation is highly relevant and will significantly advance our understanding of the antiviral mechanism of
action of SLFN proteins, which is currently unknown.

Public health relevance
PROJECT NARRATIVE Flaviviruses are important human pathogens, the clinical outcomes of their infections are unpredictable, and not specific treatment is available. We propose here to characterize an anti-flavivirus innate immune mechanism that potentially will identify biomarkers of disease susceptibility and novel therapeutic targets.